Planning and Evaluation Core

The Planning and Evaluation Core (PEC) of the Ponce Health Sciences University-Moffitt Cancer Center
(PHSU-MCC) Partnership monitors and evaluates progress toward the implementation of the goals and
objectives of the Partnership across all areas, including research, education, and community outreach. The PEC
serves as a central node for accountability and ensures that the Partnership is completing proposed aims and
objectives through its evaluative framework. The PEC evaluation processes allow for the Administrative Core
(AC) to maximize resources, identify novel directions for the Partnership, and report the progress of Partnership
cores and investigators to institutional leaders and the National Cancer Institute (NCI). The PEC maintains
internal and external advisory groups to support strategic planning, monitoring, and evaluation of Partnership
activities by assessing the relationships between aims, activities, outputs, and expected outcomes. The two
essential PEC advisory groups are the Internal Advisory Committee (IAC), and the Program Steering Committee
(PSC). The IAC and PSC work closely together within the PEC to provide guidance and recommendations to
the AC. The PEC establishes Logic Models for each Partnership component and provides continual updating to
reflect the new aims, activities, and evolution of the Partnership. The PEC, in collaboration with the Quantitative
Sciences Core (QSC), implemented the use of REDCap to track grants and publications (including journal impact
factors) submitted and obtained by the Partnership researchers to streamline tracking. The PEC is a member of
the PACHE Evaluators Special Interest Group (PACHE SIG), which works to identify common elements for the
evaluation of PACHE programs at the national level. The PEC will build on prior successes with the necessary
flexibility to adapt and respond to emerging challenges, innovations, and developments. The specific aims of the
PEC are: 1) Coordinate collection, tracking, and analysis of evaluation data for Partnership components,
processes, and activities. This provides the AC with critical data needed to initiate, terminate, or modify new and
ongoing initiatives to achieve the Partnership goals and objectives. The PEC incorporates Logic Models, webbased
relational data systems for tracking outcomes, and annual Partnership member surveys to monitor and
evaluate the effectiveness of communications, interactions, and integration between/across Partnership
components at both institutions. 2) Conduct internal evaluations of Partnership components through the activities
of the IAC. The IAC will review quarterly progress reports for the Cores and research projects and provide
summative feedback. The IAC will also collaborate with the AC to solicit and evaluate new research projects. 3)
Implement external evaluations of Partnership components through the activities of the PSC and an external
evaluation consultant. The PSC provides unbiased, rigorous, and expert evaluation of the progress of the
Partnership annually and recommends improvements throughout the grant period via quarterly meetings with
the AC.